The Role of Nuclear Receptor PPARbeta in the Regulation of Muscle Fuel Metabolism

DESCRIPTION (provided by applicant): The obesity pandemic is driving an unprecedented increase in the prevalence of type 2 diabetes. This proposal focuses on delineating the functions of the nuclear receptor PPARβ in re-programming skeletal muscle fuel metabolism. PPARβ, and the related nuclear receptor PPARα, serve as key transcriptional regulators of lipid metabolism by binding conserved DNA response elements in target gene promoters. Although this classical PPAR-mediated mechanism suggests that these factors regulate shared targets, skeletal muscle-specific PPARβ and PPARα transgenic mice exhibit drastically distinct metabolic phenotypes. PPARβ transgenics display many of the metabolic benefits of exercise in the absence of training, including increased muscle glucose uptake and utilization, improved exercise endurance, and an increase in slow-twitch muscle fibers. Conversely, PPARα transgenic mice exhibit a metabolic phenotype similar to that of the obesity-related insulin resistant state, displaying myocyte triglyceride accumulation, high fatty acid oxidation rates, glucose intolerance and decreased exercise capacity. Transcriptional and metabolomic profiling results strongly suggest that while PPARβ and PPARα regulate many overlapping gene targets, a subset of genes is PPAR isotype-specific. Recently, we discovered a novel mechanism whereby PPARβ regulates gene transcription in a manner distinct from PPARα, through cooperation with AMP-activated protein kinase (AMPK) and transcription factor MEF2A. We hypothesize that PPARβ, AMPK, and MEF2A form a complex that functions in activating transcription of target genes that play a role in re-programming skeletal muscle fuel metabolism. We will employ candidate and unbiased strategies, in PPAR transgenic mice and in primary muscle cells in culture, to further define the novel mechanisms (Aim 1) and downstream metabolic targets (Aim 2) involved in the PPARβ-mediated regulation of skeletal muscle fuel burning capacity and substrate flexibility. In the long-term, we seek to use this information to identify novel therapeutic targets aimed at the prevention and treatment of obesity-associated diseases.

Public health relevance
We are experiencing a global obesity epidemic that is overwhelming health systems worldwide due to obesity- associated diseases such as type 2 diabetes and cardiovascular disease. This project seeks to identify novel pathways that function in enhancing skeletal muscle fuel burning capacity in order to discover new approaches to abate the deleterious consequences of chronic caloric overconsumption. Our long-term goal is to identify candidate therapeutic targets within these novel pathways that act to increase skeletal muscle metabolism, a strategy to prevent and treat obesity-associated diseases.